Engineering hydrophilic/amphiphilic Vitamin B6-based super antioxidant dendrimers for controlling chronic inflammation

Project Summary
Funds are requested to purchase a new Advion CMS Expression-L Electrospray Ionization (ESI) Mass
Spectrometer (MS) with a Thin Layer Chromatography (TLC) reader, which will be installed in the lab
343A of the Dow Science building at Central Michigan University (CMU). Electrospray Ionization (ESI)
Mass Spectrometer (MS) measures molecular weights (MW) of molecules. For dendrons/dendrimers
synthesis, molecular weight is the most critical information for molecular identification because other
analytical techniques, such as NMR, cannot readily distinguish between the target dendrimer and
incomplete reaction intermediates and dendrimers in different generations. Electrospray ionization (ESI) is
a soft ionization technique, causing little to no fragmentation, which is an important criterion for analysis
of dendrons and dendrimers with high molecular weights. Without an ESI instrument, our current grant-
funded research will be greatly impacted because MS data is required at each intermediate step to move
towards the target molecule synthesis. Currently there is no reliable, well-functioning ESI MS in the entire
CMU community. The TLC plate reader measures molecular weight of each spot on the TLC plate and help
locate the target dendrons (dendrimers) rapidly, contributing to enhancing work efficiency and saving
overall cost and time in purification. In summary, (i) ESI MS is the most important analytical instrument
for monitoring synthesis reactions of dendrimers/dendrons. (ii) This supplementary funding will allow us
to train undergraduate/graduate research students. We believe that procurement of a state-of-the-art
analytical instrument (ESI MS spectrometer) with this Administrative Supplement will help accelerate the
pace of the proposed research as well as help students acquire a cornerstone MS technique, which is a
desirable skill for future employment and graduate school.

Public health relevance
Public Health Relevance Statement (Narrative attachment) We will synthesize safe, powerful, and hydrophilic/amphiphilic antioxidant dendrimers that would be beneficial for the prevention and treatment of diseases that have a strong association with oxidative stress (chronic inflammation), such as cancer, diabetes, asthma, atherosclerosis, arthritis, and neurodegenerative diseases. The synthesized hydrophilic/amphiphilic super antioxidants in a dendritic architecture will be tested to investigate their protective effects on biomolecules and anti-inflammatory action on cells against free radicals.